Discovering Fusobacterium nucleatum's Impact on Breast Cancer Progression and Treatment with POx Micelle Technology

PROJECT SUMMARY
Breast cancer (BC) is a complex and heterogeneous disease, further complicated by the discovery of tumor-
specific microbiota, including Fusobacterium nucleatum (F. nucleatum), which has been detected in 30% of BC
cases and is associated with increased malignancy. While F. nucleatum has been correlated with worse clinical
outcomes in BC patients, the mechanisms underlying its effects remain unclear, partly due to limited research
on how this bacterium alters tumor biology and immune responses in immunocompetent, clinically relevant BC
models. Our preliminary studies reveal that F. nucleatum infection accelerates triple-negative BC (TNBC) growth.
This raises the critical question of whether F. nucleatum fosters a pro-tumorigenic, immunosuppressive tumor
microenvironment (TME) that diminishes the efficacy of chemotherapy in BC. We hypothesize that F.
nucleatum and its metabolites drive an immunosuppressive TME, decreasing immune surveillance of the cancer
by T-cells and impairing the response to chemotherapy. Targeting the infection will restore efficacy by increasing
immune surveillance, transforming infected tumors into ‘hot’ tumors that are more responsive to treatment. In
Aim 1, we will characterize the relationship between F. nucleatum infection and changes in the TME, and their
collective role in promoting disease progression in BC. We will use two immunocompetent models of TNBC, 4T1
and T11-APOBEC (T11-AB), which have been comprehensively profiled and demonstrate strong genomic and
genetic similarities to human TNBC. We will quantify the TME metabolome, transcriptome, and immune cell
populations, alongside primary tumor growth, metastatic spread, and lifespan. We will perform the most
extensive immunophenotyping of F. nucleatum-infected BC to date using spectral flow cytometry. Given the
limited research on F. nucleatum’s role in BC, our study will address a critical gap by generating a detailed profile
of the functional and immune alterations caused by this infection and its relation to disease outcomes. In Aim 2,
we will tackle the challenge of eradicating F. nucleatum without disrupting the gut microbiota, which is crucial for
maintaining immune function and overall health. Conventional antibiotic treatment can lead to dysbiosis, impair
immune responses, and potentially promote tumor progression. To avoid this, we will use a novel combination
therapy involving multi-drug polymeric micelles (MDPMs) to co-deliver anticancer drug, paclitaxel and the
antibacterial antibiotic metronidazole directly to the tumors via intravenous administration. This approach aims
to bypass the gastrointestinal tract, targeting both cancer and bacteria in the TMBC tumor while minimizing off-
target antibiotic effects and preserving beneficial gut microbiota. By integrating these strategies, our study will
provide critical insights into how F. nucleatum contributes to BC progression and offer a promising, microbiome-
sparing therapeutic strategy for treating bacteria-infected tumors.

Public health relevance
PROJECT NARRATIVE Fusobacterium nucleatum, an anaerobic bacterium in oral cavities, colonizes tumors and is found in 30% of breast cancers, making them more aggressive. We aim to understand how this bacterium and its metabolites change the cancer immune environment, promoting tumorigenesis and complicating treatments, and use this knowledge to develop better therapies for bacteria-infected tumors. Using advanced nanoparticles, we propose delivering anticancer and antibacterial drugs simultaneously to improve patient outcomes and preserve the essential gut microbiome.